Unraveling neuronal and molecular mechanisms of flexible social behavior in mice

PROJECT SUMMARY
Developmentally wired programs of social interactions in animals enhance reproductive success, yet these underlying
neural circuits also allow for flexibility in behavior, such as modulating behavior in response to past experiences. The
mechanisms enabling such flexibility in innate social behaviors remain poorly understood. This project aims to define the
experience-driven neural mechanisms that enhance behavioral performance in male mating. We hypothesize that
experiential changes in male mating are governed by neural plasticity within the circuits controlling this behavior, focusing
specifically on preoptic hypothalamus neurons (POA) expressing tachykinin receptor 1 (POATacr1), a critical population that
regulates male mating. To achieve our objectives, we will first delineate the afferent inputs onto POATacr1 neurons. We will
employ retrograde tracing and optogenetic manipulations to identify and characterize cell populations projecting to
POATacr1 and their role in mating. Second, we aim to elucidate the cellular and electrophysiological mechanisms underlying
mating experience-driven plasticity. This includes measuring synaptic transmission onto POATacr1 neurons and
characterizing mating experience-regulated cellular dynamics using in vivo 2-photon imaging. Furthermore, we will
identify molecular pathways underlying mating experience-driven plasticity through deep sequencing to identify and
functionally interrogate candidate genes regulated by mating experience. If successful, our project will reveal novel
mechanisms underlying circuit plasticity during experientially driven changes in mating behavior, with potential
implications for understanding reproductive behavior in health and disease. The interdisciplinary approach employed will
provide insights into the interplay among genes, circuit plasticity, and innate behaviors, establishing a platform for future
independent research.

Public health relevance
PROJECT NARRATIVE This research aims to elucidate the neural and molecular mechanisms underlying experience-driven changes in an innate social behavior in male mice, providing fundamental insights into flexibility in social interactions. Understanding these mechanisms may point the way to therapeutic strategies for addressing conditions such as declining libido, which affects 15-20% of the human population. Ultimately, this project will advance fundamental knowledge about how the brain regulates behavior and may enhance the quality of life by paving the way for new treatments and interventions for social and behavioral disorders.